The Mechanistic Effects of Combined Testosterone Therapy and Exercise on Axial Bone and Muscle Post-Hip Fracture

Project Summary/Abstract
Osteoporotic fractures have substantial public health impact and better approaches are needed to maximize
the functional recovery from hip fracture. This ancillary study will build upon a funded parent trial of exercise
and testosterone in 3 groups of women recovering from hip fracture: controls, exercise + placebo (Ex+Pl), or
exercise+ testosterone (Ex+T). The parent study goal is to investigate the use of an anabolic hormone to
enhance functional recovery beyond exercise interventions. The objective of this study is to investigate the
anabolic responses of low-dose transdermal testosterone on the skeleton and muscle in older women
recovering from hip fracture, by adding mechanistic assessment of volumetric bone mineral density, muscle
area and density as well as measures of testosterone and downstream metabolites in the androgen pathway
and the follistatin/activin pathway. The central hypothesis is that exercise and testosterone will increase
skeletal strength, muscle area and muscle density to a greater extent than either Ex+Pl or a Control group;
also that the magnitude of these changes will be related to the magnitude of change in specific sex steroid
concentrations and also increases in follistatin, which is up-regulated by testosterone binding to the androgen
receptor. This is a unique, time-sensitive opportunity, as initiation of the additional imaging and serum
collection is required to address our aims.
Our study aims will compare in three groups of women with recent hip fracture (controls, Ex+Pl, and Ex+T), the
6-month changes in important QCT derived bone and muscle outcomes (volumetric trabecular and cortical
bone mineral density, volumetric integral bone mineral density, and vertebral strength using finite element
analysis of the spine, as well as paraspinal muscle area and muscle density). Most importantly, the study will
also determine the relative contributions of 6-month changes in testosterone, free testosterone,
dihydrotestosterone (DHT), follistatin, and estradiol to concomitant changes in the bone and muscle outcomes.
Compared to Ex+Pl or to a control group, an Exercise with Testosterone regimen is hypothesized to produce
significantly greater improvements in the bone and muscle outcomes. Further, the 6-month changes are
hypothesized to be directly associated with increases in free testosterone, the combined levels of circulating
testosterone + DHT, and increases in follistatin, but not with changes in estradiol.
This project will robustly enhance the scientific content and value of the parent study, leveraging resources to
improve understanding of the pathways involved in bone and muscle responses to hormonal and exercise
interventions post-hip fracture. Outcomes from this project are likely to identify novel targets for therapeutic
interventions, fracture prevention and provide useful surrogate markers of clinical outcomes of hip fracture.

Public health relevance
Project Narrative/Public Health Relevance Statement We will investigate the hormonal mechanisms of action for exercise and transdermal testosterone on the skeleton and muscle in a parent study of frail older women during recovery from hip fracture. The current project will enhance the scientific content and value of the parent study, by improving our understanding of how these treatments improve bone and muscle outcomes. Results from this project may identify novel targets for future therapeutic interventions to speed recovery from hip fracture as well as providing useful surrogate markers to monitor recovery.